Investigations CONNECTing Cancer and Aging (I-CONNECT)

By 2030, three-quarters of the 22 million US cancer survivors will be 65 and older and the number of older
Hispanic and Black survivors will have grown three times faster than Whites. These shifting demographics are
driving a crisis in cancer care due to a paucity of evidence to guide care for older survivors, especially older
racial/ethnic survivors for whom data is virtually lacking. Filling these gaps will require an understanding of
several complex multidirectional relationships at the intersection of health disparities, aging and cancer.
Compared to older White survivors, older racial/ethnic minority survivors have had more lifetime exposures to
adverse social determinants of health. These exposures accelerate aging processes. Aging increases the risk
of developing cancer through accumulated damage and mutations. Cancer and its therapies, in turn, are disease
drivers of aging. Together, these intersecting forces are likely to exacerbate current racial/ethnic cancer
disparities in the health and quality of life of older survivors. The vision for this Outstanding Investigator Award
is to fundamentally shift how we approach cancer disparities by providing a mechanistic understanding of the
role of cellular aging in the relationships between social determinants of health and survivorship outcomes. I will
use a conceptual model that integrates a multi-level disparities framework with oncology and geroscience
perspectives to conduct research using transcriptomic and other -omics analyses, epigenetics, machine learning,
mediation models, meta-synthesis and population simulation methods. The broad goals of my transdisciplinary
research program are to: 1) discover cellular aging processes in large cohorts of older Black, Hispanic and
White survivors that explain relationships between health determinants and quality of life (e.g., via stress
signaling and downstream effects on cellular aging via inflammatory gene expression), 2) define mechanistic
pathways suggested by cohort results and test the impact of interventions targeting those pathways in a
preclinical model of cancer survivorship and 3) translate results to practice and policy. During my continuously
NIH-funded research career, I have made transformative contributions that support my proposed research
program. There are few population scientists with the unique background and proven track record to successfully
conduct this in-depth research program spanning the full translational continuum from preclinical to cohort
studies and practice and policy. Collaboration with scientists from outside my discipline will support my success
and generate novel insights. The newly established Georgetown Lombardi Institute on Cancer and Aging that I
lead and exceptional institutional commitment and infrastructure provide an exceptional environment. This
Outstanding Investigator Award will provide me with the stability needed to accelerate knowledge in an
understudied research area with high public health significance and clinical relevance. Identification and testing
of aging mechanistically-based interventions will support efforts to tailor clinical care for the burgeoning older
minority survivor population and could to transform how we approach cancer disparities in the context of aging.

Public health relevance
We lack sufficient data about the complex relationships between cancer and aging, leaving survivors and their oncology teams with insufficient evidence to guide chronic disease and cancer care. My cancer and aging laboratory will lead teams of basic, clinical and population science researchers to fill this gap by providing a mechanistic understanding of the role of aging processes in population health outcomes. We will use this paradigm to conduct human and animal studies to Identify and test aging mechanistically-based interventions that can support efforts to tailor clinical care for the growing cancer survivor population.